Training in Biotechnology: Emphasis in Protein Chemistry

This is an application to renew the Biotechnology Training Program (BTP; http://nihbiotech.wsu.edu/) grant first
awarded to Washington State University (WSU) in Fall, 1989. The grant was competitively renewed in 1994,
1999, 2004, 2009 and 2014 and we are now seeking funding for another five years. During our last renewal period
the Program continued to gain in importance and recognition, at WSU and beyond, as an excellent site to obtain
interdisciplinary training in concepts and technologies important in biotechnology. The success of the BTP is
based on many factors including the continuous and generous support provided by our University. Since the BTP
started, WSU has directly contributed significant funding to the Program for a number of purposes, including
supplemental support for NIH-funded Trainees, support for additional non-NIH funded Trainees, support for a
part-time BTP administrative assistant, support to assist with BTP student recruitment and retention, and support
for various other Program activities. For this renewal application WSU has pledged to increase this support
beyond “carry forward' levels by adding an additional WSU-sponsored Trainee, bringing the number of WSU
Trainees to 10/year.

Public health relevance
Since its origin in 1976, the American biotechnology industry has grown into a mature sector of the economy, with 2016 revenues of over US$139.4 billion. Furthermore, biochemistry and biophysics is designated as a high growth industry by the U.S. Department of Labor with National Employment Data projected to increase by 11% from 2016 to 2026, faster than the average for all occupations. Our Biotechnology Training Program is designed to address the current and future needs of the growing biotechnology industry by providing interdisciplinary training in biotechnology with a major emphasis on the fundamentals and complexities of protein chemistry.